Determining how neurotensin mediates valence processing and compulsive cocaine seeking

PROJECT SUMMARY/ABSTRACT
A hallmark of substance use disorders is continued drug use despite profound adverse consequences. While
studies in rodents have suggested that leveraging both positive and negative valence processing can affect
this compulsive pattern of reward-seeking behavior in conflict with punishment, the underlying mechanisms
that regulate valence processing and guide ultimate behavioral selections remain unknown. Studies have
shown that the basolateral amygdala (BLA) projections to the nucleus accumbens (BLA-NAc) preferentially
encode positive valence, including sucrose and cocaine predictive cues and drive approach behaviors, while
projections to the central nucleus of the amygdala (BLA-CeM) encode negative valence and drive avoidance.
This evidence strongly suggests that BLA-NAc and BLA-CeM neurons could encode valence processing
during compulsive cocaine seeking and collectively mediate decision-making during ongoing behavior. This
proposed project aims to identify basic neural substrates that guide the valence assignment among BLA-NAc
and BLA-CeM neurons (K99 Phase), and examine whether the same mechanism contributes to the encoding
of compulsive cocaine-seeking (R00 Phase). Preliminary data suggest that neurotensin (NT), a 13 amino acid
peptide, plays a critical role in mediating valence processing in the BLA. Specifically, activation of terminals of
the paraventricular nucleus of thalamus (PVT) NT neurons in the BLA enhanced reward learning and impaired
punishment learning, while disruption of the PVT-BLA NTergic signaling produced the opposite behavioral
effects. During the K99 phase of the award, the applicant will receive training on using CRISPR-Cas9 mediated
gene manipulation to interrogate NTergic contributions without affecting glutamate and applying machine
learning-based computer vision tools and classification algorithms to extract distinct behavioral motifs and
decode neural correlates. This training will allow the applicant to investigate the specific roles of NT in valence
assignment and coding properties of BLA neurons during valence processing. To test this, the applicant will
examine the impact of the CRISPR-mediated knockdown of the Nt gene in BLA-projecting PVT neurons on
reward and punishment learning (Aim 1) and the effects of the knockdown on valence encoding properties of
BLA-NAc and BLA-CeM neurons during a reward and punishment discrimination task (Aim 2). After securing
an independent research position, the applicant will begin the R00 phase of the award by combining these
approaches gleaned from the K99 phase with applicant’s expertise in studying cocaine addiction with self-
administration and punished reward-seeking paradigms, to investigate how PVT NTergic inputs modulate the
encoding of compulsive cocaine-seeking (Aim 3). Together, the training and scientific advances that will be
achieved through the completion of this project will allow the applicant to secure a tenure track faculty position
in a top research university and provide critical pilot data necessary to prepare the first R01 application to study
more distributed neural pathways that govern motivated behavior and compulsive drug-seeking.

Public health relevance
PROJECT NARRATIVE This project aims to explore how neuromodulation, specifically neurotensin, plays a critical role in valence assignment in the basolateral amygdala, a site identified as a divergence point in circuits mediating positive and negative valence. This project will test the hypotheses that neurotensin directs valence-specific information to the appropriate downstream BLA projections during valence processing and modulates compulsive cocaine- seeking behavior. The proposed research project will broaden our understanding of the fundamental neuromodulatory mechanisms underlying valence processing and motivated behavior and identify neurotensin as a novel target for treating valence-disorders including substance use disorders.